Evaluation of a novel Tc-24 ELISA test in post-treatment efficacy for Chagas disease.

PROJECT SUMMARY
Chagas disease is a neglected tropical disease endemic to Latin America but is increasingly being detected
in the United States. Chagas disease is caused by the Trypanosoma cruzi (T. cruzi) parasite and presents itself
in two phases: an acute phase and a chronic phase. The diagnosis of both phases is challenging as patients
can be asymptomatic or have nonspecific symptoms. If untreated, the acute infection progresses to a chronic
phase where 20 ‒ 40% of patients will develop life-threatening illnesses, including cardiomyopathy, heart failure,
or cardiac arrest.
Acute infection can be detected by microscopy; however, the level of parasitemia during chronic infection
often drops below the limit of detection of these techniques, making it unsuitable for diagnosis. Therefore, the
diagnosis of chronic infection relies solely on serological detection of anti-T. cruzi antibodies can persist in the
blood throughout the life of the infected individual. However, existing serological tests are prone to inconclusive
or false-negative/positive results due to inadequacies of the native T. cruzi capture proteins used in these assays
and for differences in the six discrete typing units (DTU) subtypes. For this reason, the WHO and PAHO
recommend testing using at least two different serological techniques to diagnose Chagas infection. In the United
States, discordant results from these two tests require the sample to be forwarded to the CDC for additional
testing to confirm diagnosis. This repetitive testing process imposes a significant resource burden on the
healthcare system, and the poor performance of existing Chagas serological tests can lead to increased disease
transmission and life-threatening illness due to misdiagnosis. Therefore, this project aims to develop and validate
a highly sensitive serological assay for detecting all geographic variances of T. cruzi infection with a single test.
This assay will employ a collection of carefully designed recombinant T. cruzi antigens, enabling high-sensitivity
detection of all T. cruzi strains. The rationale for the proposed research is supported by the applicants’ preliminary
data demonstrating the generation of a recombinant T. cruzi antigen (Tc24) that can accurately detect anti-T.
cruzi IgG in patient samples from multiple Latin American countries and to provide a test-of-cure in a prospective
longitudinal post-treatment study. To achieve this goal, we will pursue the following specific aims:
1) Optimize a Chagas Tc24 Direct ELISA and high repetitive region quantitative PCR for T. cruzi
2) Use Tc24 ELISA and qPCR to provide a proof-of-principle for a test of cure in chronic Chagas
This approach is innovative because it combines the use of a collection of carefully designed recombinant T.
cruzi antigens for detecting all geographic strains of T. cruzi while exhibiting no cross-reactivity with other
parasites with a single test and it is significant because it will provide a test-of-cure and post-treatment efficacy
for people with Chagas disease.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant for disease management because it will provide clinicians with an accurate diagnosis and test-of-cure of chronic Chagas infection with a single test. Delays in diagnosis and treatment can result in life-threatening illness and increased morbidity and mortality risk. Thus, the proposed research is relevant to NIAID’s mission by advancing neglected tropical disease research through the development of new diagnostics tools to improve the diagnosis and management of patients with Chagas disease, which will ultimately improve patient outcomes.